Integration of Compliance Chambers into Diaphragm Displacement Pump to Double the Pumping Flow of Pediatric Paracorporeal Pulsatile Ventricular Assist Device

The paracorporeal Berlin Heart EXCOR is the only FDA-approved ventricular assist device (VAD) for
pediatric patients. This pulsatile diaphragm displacement pump (DDP) is small/light weight to facilitate pediatric
patient ambulation. However, EXCOR efficiency is only 50% since it withdraws and pumps blood at different
times (interrupted pulsatile flow). This generates a high peak blood flow rate, which may cause blood damage.
A paracorporeal continuous flow PediMag VAD has also been used in smaller children. This centrifugal pump
is highly efficient due to the constant flow through the drainage/infusion cannulas, but the PediMag pump head
must be attached to a bulky/heavy motor, which hinders ambulation. We previously developed a transapical to
aorta (TAA) double lumen cannula (DLC) for a minimally invasive ambulatory LVAD, which showed excellent
96 hr performance/hemocompatibility in neonate lambs. Our ultimate goal is to develop an efficient, minimally
invasive, paracorporeal LVAD system for pediatric patients, which combines the small size/weight (ambulation
potential) of current interrupted pulsatile flow pump (e.g EXCOR) and the current high efficiency of a
continuous flow pump (e.g PediMag). The enabling technology is a compliant diaphragm displacement pump
(cDDP), which has compliance chambers integrated into the drainage and infusion outlets to double blood flow.
The cDDP will be high performing due to: 1) noninterrupted/continuous blood flow; 2) infusion/drainage
compliance chambers that decrease cDDP afterload/increase cDDP preload. The lower peak drainage/infusion
flow of the cDDP will also reduce blood trauma. Preliminary data showed that adding compliance chambers
increased pumping flow from 1.1 to 2.6 L/min and decreased peak flow rate. The Phase I SBIR objective is to
design and fabricate a cDDP working prototype with optimal compliance chambers size. This cDDP will be
tested in lambs with our previously developed TAA DLC. Specific Aim 1: To design, fabricate, and bench
test a cDDP. Compliance chambers will be integrated into the cDDP drainage and infusion outlets. The cDDP
will be made of polycarbonate housing with a polyurethane diaphragm in the middle. A tricuspid valve will
connect the cDDP housing to the two small silicone compliance chambers. The final prototype will be tested for
1 week in a 37% glycerin mock loop for performance/reliability/durability. Specific Aim 2: To test the cDDP
working prototype in lambs. The cDDP will be combined with the TAA DLC to form a less invasive,
ambulatory LVAD, which will be tested in 10-15 kg lambs (n=9) to evaluate 6 hr performance/reliability and
initial biocompatibility. Prototype design/fabrication/bench testing will be done at W-Z Biotech, and the lamb
studies will be done at the University of Kentucky. Rather than fine-tuning existing technology, our cDDP is a
novel invention, which will enable a pulsatile paracorporeal VAD with doubled efficiency. This technology can
also be used in adults and may significantly impact cardiogenic shock/bridge to heart transplant management.

Public health relevance
We are proposing to develop an efficient, minimally invasive paracorporeal left ventricular assist device (LVAD) system for pediatric heart failure patients, which combines the small size/weight of interrupted pulsatile flow pump and the high efficiency of continuous flow pump. The enabling technology is a compliant diaphragm displacement pump (cDDP) with integrated drainage and infusion compliance chambers. When coupled with our previously developed minimally invasive transapical to aorta double lumen cannula, this cDDP will enable continuous blood flow with pulsatility to improve VAD system efficiency, potentially improving outcomes.